Engagement Core

The Engagement Core serves as the central engagement, translation and dissemination, and training component of the proposed Learning Disabilities Research Center (LDRC), Learning Disabilities Translational Science Collective: Building on the Florida LDRC. To support this broad objective, the Engagement Core has three specific aims (1) bidirectional research engagement with educators, families, and others who support children with specific learning disabilities (SLD), (2) translation and dissemination of research findings, and (3) structured project-embedded research career enhancement efforts for early career scholars and community members, including opportunities for the broader, external research community beyond the LDRC. The Engagement Core will collaborate with the Administrative Core, Data Management Core, and Project Leads to accomplish these specific aims.